Pathology and Biochemistry Core

PROJECT SUMMARY: CORE B
Accumulation of inflammatory macrophages as well as innate and adaptative immune cells is a common feature
of cardiometabolic diseases, including atherosclerosis, obesity and non-alcoholic fatty liver diseases.
Inflammation in metabolic tissues accelerates atherosclerosis and metabolic dysfunction. The ability to examine
changes in gene expression in immune cells, particularly macrophage populations, in the plaque, adipose tissue
depots, and liver during cardiometabolic disease provides insights into that key pathways that promote or inhibit
the inflammatory response and their corresponding effects on pathologic processes in these tissues. As such, a
Core will be established to: 1) isolate and quantify macrophage and other immune cell subsets from
atherosclerotic plaque, adipose tissue and liver by FACS; 2) monitor changes in metabolic parameters within the
systemic circulation, atherosclerotic plaque, adipose tissue and liver; and 3) perform sectioning and histologic
quantification of atherosclerotic plaques, fat depots and liver morphology. These procedures are key to the
successful execution of the Aims of all three projects in this Program Project, and centralizing the
immunohistochemical and biochemical assays will ensure consistency and reproducibility, which in turn will
maximize the efficiency and productivity of the scientists within each project.